Inhibition of wild-type IDH1 as a ferroptosis-inducing therapeutic approach for the treatment of malignant glioma.

Our laboratories recent studies (Stegh and colleagues, Cell Report, 2017; Wahl and colleagues, Cancer
Research, 2017) indicated that IDH1 wild-type (IDH1-wt) is overexpressed in 2/3 of HGG (referred to here
as `IDH1-wthigh GBM') that lack IDH1R132H mutation. Both
alone
while
genetic and pharmacological inhibition of wt-IDH1,
and in combination with radiation therapy (RT) slows the growth of patient-derived HGG xenografts 5,6
overexpression of wt-IDH1 promotes intracranial HGG growth molecular levels, wt-IDH1 high
,
. On GBM
produce excess NADPH, which serves as a rate-limiting reductant that drives the biosynthesis of mono-
unsaturated fatty acids (MUFAs). In addition, enhanced NADPH production increases glutathione (GSH)
level, reduces reactive oxygen species (ROS), activates phospholipidperoxidase glutathione peroxidase 4
(GPX4)-drivenlipid repair, and dampensthe accumulation of polyunsaturated fatty acid (PUFA)-containing
lipid peroxides, known executioners of ferroptosis.
Based on these findings, we hypothesize that wt-IDH1 through enhanced lipid repair, heightened MUFA
biosynthesis and displacement of oxidizable PUFAs from plasma membrane phospholipids antagonizes
ferroptosis, a recently discovered form of cell death has rapidly gained recognition as a paradigm shifting
strategy to specifically target cancer cells. We further hypothesize that wt-IDH1 inhibition cooperates with
known inducers of ferroptosis, including RT and immune-mediated checkpoint inhibition, to antagonize HGG
progression. For the pharmacological inhibition of wt-IDH1, we have used and characterized 13i, a first-in-
class competitive ???-unsaturated enone, developed by AbbVie. 13i potently inhibits wt-IDH1 enzymatic
activity, by covalently binding to the NADP+ binding pocket. Our data indicate that 13i promotes ferroptosis,
is brain-penetrant, and like genetic ablation, reduces progression and extends the survival of IDH1-wthigh
HGG bearing mice, alone and in combination with RT. We will test these hypotheses in three Specific Aims:
Aim 1: Determine how wt-IDH1 impacts de novo fatty acid biosynthesis and membrane phospholipid
composition to inhibit ferroptosis.
Aim 2. Determine how wt-IDH1 promotes GPX4-dependent lipid repair and antagonizes ferroptosis.
Aim 3: Determine if genetic and pharmacological inactivation of wt-IDH1 amplifies ferroptosis in
response to RT and immune checkpoint blockade and antagonizes HGG progression.
Objectives and long-term goals. We will credential wt-IDH1 as regulator of ferroptosis in HGG and will
validate the pharmacological inhibition of wt-IDH1 using a novel NADP+ competitive inhibitor as a therapeutic
strategy. Results from these studies are expected to inform the design of IND-enabling studies evaluating
the potential of 13i as adjuvant for anti-HGG therapy.

Public health relevance
Project Narrative This proposal will investigate the role of the metabolic enzyme isocitrate dehydrogenase-1 (wt-lDH1) in high grade glioma (HGG), and by evaluating the novel wt-lDH1-specific inhibitor, 13i, developed by AbbVie, will develop a novel therapeutic strategy to target wt-lDH1 activity for the treatment of HGG.